THE EFFECT OF LABELED BENTIROMIDE ON D-XYLOSE ABSORPTION

In preliminary testing, a group of investigators at the University of Colorado found that D-xylose absorption was suppressed when given with their modified PABA test. Our group has developed a kinetic model of D-xylose absorption that can characterize D-xylose absorption into two rate constants: Ka, rate of absorption reflecting mucosal function, and Ko, rate of nonabsorptive loss reflecting D-xylose lost in the GI tract.